ALPHA GALACTOSIDASES A AND B--MOLECULAR AND CELLULAR MECHANISMS

The purpose of this study is to determine the biochemical and molecular genetics of Fabry disease. Efforts are directed to identify the different disease gene mutations and evaluate genotype/phenotype correlations. A major focus of this project is to evaluate enzyme replacement therapy using a KO mouse model to establish enzyme dose and dose schedule, and then to initiate an FDA approved trial of replacement therapy.